ENERGY EXPENDITURE IN END STAGE RENAL DISEASE

Measure resting energy expenditure in end stage renal disease patients at different stages of their renal failure including prior to initiation of renal replacement therapy and during chronic hemodialysis and / or peritoneal dialysis. We have had success with recruiting efforts in the first year. We will continue recruitment and should complete our study in a timely manner.